Identifying and Addressing Social Determinants of Health to Reduce the National Burden of and Inequities in Dementia

PROJECT SUMMARY/ABSTRACT
Alzheimer’s disease and related dementias (ADRD) are an escalating national crisis that shapes overall levels
of population health including average life expectancy. Critically, in order to effectively address this crisis, it is
imperative that we identify its root causes, which may include social determinants of health (SDoH) such as
education spending and social mobility, and that we modify these root causes through corresponding policies.
While a handful of SDoH have been shown to predict cognitive decline and ADRD, important questions remain
about which SDoH are root social drivers i.e., have the greatest impacts. Despite increasing calls for
comparative assessments to unpack and address the root causes—the social determinants—of ADRD, we lack
knowledge on the relative ADRD burden and economic impacts associated with modifying SDoH, including
policies such as the social security benefits tax. Furthermore, we have yet to establish which subpopulations
are most affected by SDoH. Given this information, there are critical needs to accurately estimate SDoH impacts,
including by subpopulation; and to translate these estimates into priority-setting tools including impacts on ADRD
burden and costs. Left unaddressed, these critical needs will hinder the development of policies to more
effectively reduce ADRD burden and inequities. Our overall objective is to use large multilevel, longitudinal
datasets and quasi-experimental approaches to construct the first comparative assessment evidence
base on the social drivers of ADRD burden and inequities. We will accomplish our overall objective by pursuing
the following specific aims using data in adults age 50+ from: the nationally-representative Mortality Disparities
in American Communities Study, linked to national mortality databases; the nationally-representative Health and
Retirement Study, linked to Medicare claims data; and the NIH’s All of Us Program, a multiethnic study linked to
electronic health records (EHR) data on diagnoses/treatments of health conditions: Aim 1) To assess the
impacts of area-level SDoH including state policies as protective factors against ADRD mortality, that
may vary across health disparity populations; Aim 2) To evaluate the impacts of area-level SDoH on
memory decline in middle-aged adults and incidence of cognitive impairment and dementia in older
adults; Aim 3) To explore the mechanisms through which area-level SDoH may protect against ADRD
incidence and cognitive impairment/decline, including physical/mental health disorders and biomarkers;
and Aim 4) To ascertain which area-level SDoH, if modified, are expected to yield the greatest reductions
in levels of and inequities in ADRD burden and costs. Regarding impact, we will identify the most promising
SDoH on which to intervene to yield improvements in ADRD burden and inequities. We will further establish the
pathways to differential vulnerabilities by subpopulation. By translating estimates into population health metrics,
we anticipate our project will have high translational impact through guiding policymakers' evidence-based
decisions about policies to more effectively reduce the burden of and inequities in ADRD among Americans.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH RELEVANCE) Using three large, longitudinal studies of Americans, this project will construct the first comparative assessment evidence base on the estimated impacts of modifying SDoH to mitigate risks of cognitive decline and ADRD incidence and mortality in adults in the United States, hence directly responding to calls from NIH for comparative assessments in prevention research. We will further establish how vulnerabilities to effects by subpopulation may explain inequities in ADRD burden. Over the long term, by translating our estimates into population health and economic metrics, we anticipate that our project will have high translational impact through guiding policymakers' evidence-based decisions about public policies to more effectively reduce the burden of and inequities in ADRD among Americans.